Acetylation and contraction-mediated glucose uptake

PROJECT SUMMARY
Contraction-stimulated glucose uptake is important to the maintenance of ATP production during exercise,
especially exercise of high-intensity. It is also a cornerstone for the treatment and prevention of clinical
hyperglycemia and the development of type 2 diabetes. Thus, understanding the regulation of contraction-
stimulated glucose uptake is important for the development of strategies to optimize skeletal muscle glucose
metabolism. The long-term objective of this research is to elucidate the mechanisms that regulate contraction-
stimulated glucose uptake. The fundamental premise of this application is that lysine acetylation of GLUT4-
trafficking proteins is necessary for contraction-stimulated glucose uptake. Accordingly, in this application our
primary objective is to elucidate the importance of the acetyltransferases, p300 (E1A binding protein p300) and
CBP (cAMP response element-binding protein binding protein) to contraction-stimulated glucose uptake, and
to identify the GLUT4 trafficking proteins that are acetylated in response to contraction. Our central hypothesis
is that p300 and CBP regulate contraction-stimulated glucose uptake through acetylation of GLUT4-trafficking
proteins, and that they do so independent of their common role as transcriptional regulators. To address this
hypothesis, we will measure basal and contraction-stimulated glucose uptake and plasma membrane GLUT4
abundance in mouse skeletal muscle in which p300 and CBP acetyltransferase activity is acutely regulated.
Specifically, Aim #1 will investigate the contributions of p300/CBP to contraction-stimulated glucose uptake and
plasma membrane GLUT4 translocation, including the importance of gene transcription to their regulatory
effects. Aim #2 will define the GLUT4 trafficking proteins that are acetylated in response to contraction,
including the contributions of p300/CBP. Altogether, these studies will provide insight into the contribution of
p300/CBP and lysine acetylation to contraction-stimulated glucose uptake. Altogether, because of this work, an
improved understanding of the signalling that regulates glucose uptake by skeletal muscle is anticipated, which
by extension is expected to translate into tangible benefits to human health.

Public health relevance
PROJECT NARRATIVE Exercise and skeletal muscle contraction are a cornerstone intervention for the treatment and prevention of clinical hyperglycemia and type 2 diabetes, via their ability to stimulate glucose uptake from the blood. These experiments will define how contraction-stimulated glucose uptake is regulated at the post-translational level, with particular focus on the roles of the p300 and CBP acetyltransferase enzymes. Knowledge gathered will bring forth novel insights into maximizing skeletal muscle glucose uptake, including during and after exercise.